Antigenic targets and commensal dependence of natural Tgammadelta17 cells

? DESCRIPTION (provided by applicant): Interleukin (IL)-17 plays a key role in anti- bacterial and anti-fungal immunity. In acute infections, a rapid IL-17 response must be induced quickly without prior antigen exposure, and γδ T cells have been identified as the major initial IL-17 producers. In particular, some γδ T cells make IL-17 within hours after an immune challenge. These cells appear to acquire the ability to respond to IL-1 and IL-23 and to make IL-17 naturally in naïve animals. They are known as the natural Tγδ17 (nTγδ17) cells. The critical rle of nTγδ17 cells in host immune defense is well documented. But, the molecular cues that drive this response remain elusive. The rapidity of the nTγδ17 response, and the apparent lack of explicit T cell receptor (TCR) engagement for its induction have led to the view that this is a cytokine (IL-1, IL-23)-mediated response. However, pharmacological inhibition or genetic defects in TCR signaling drastically reduces the nTγδ17 response and/or their presence, suggesting that antigen recognition is important to their function. In addition, the appearance of nTγδ17 cells in the gut depends on the presence of specific commensal bacteria. But, the molecular cues for this process in not clear. Moreover, although the importance of nTγδ17 cells in immune defense is well demonstrated in mouse models of infection, whether there is a human counterpart is unclear. This application seeks to address these issues. This study should shed new light on the molecular cues that drive nTγδ17 cell function, which is important in initial immune defense and has a profound influence on the development of the inflammatory response. It may also have important implications in human immune response to infectious diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE Interleukin (IL)-17 plays a key role in initiating many inflammatory responses. In acute infections, a rapid IL-17 response must be induced quickly without prior antigen exposure, and γδ T cells have been identified as the major initial IL-17 producers. Our proposal aims to better understand the molecular cues that drive this response, which is important in defending against microbial invasion and has a profound influence on the development of the inflammatory response. It may have important implications in the human immune response to infectious diseases.